Core 3: Biospecimens and Pathology Core

CORE 2. BIOSPECIMENS AND PATHOLOGY: ABSTRACT
Histologic and molecular analyses of lymphoma tissue specimens are a cornerstone of each SPORE Project, as our investigators aim to close the knowledge gap regarding lymphoma biology across patient groups and propose novel diagnostic and therapeutic strategies. The expert hematopathologists directing the Biospecimens and Pathology Core (Core 2) will ensure accurate tissue collection, render pathologic characterization of lymphoma tumors, and provide critical support for all SPORE Projects through its comprehensive infrastructure for biospecimen collection, pathology review, multiplex imaging, and molecular analysis. In addition to using conventional histomorphologic, immunohistochemical and molecular techniques, Core 2 has also developed methods to create tissue derivatives (e.g., tissue microarrays, RNA, DNA) suitable for identification and validation of molecular markers that may contribute to lymphoma progression and disease resistance. To enhance the usability of specimens, Core 2 will digitize slides for hematoxylin and eosin (H&E), immunohistochemistry, and multiparametric imaging to generate a pathology image library accessible to all SPORE Project, Career Enhancement Program, and Developmental Research Program investigators. Core 2 will offer advanced imaging and immunophenotypic services crucial for molecular analyses. This includes multiplexed immunohistochemical and immunofluorescence staining, and spatial transcriptomics profiling with state-of-the-art technologies such as CODEX and COSMx 6k imaging. In addition, Core 2 will support development of patient-derived tumor xenografts (PDXs) with histopathologic characterization and creation of PDX-derived cell lines and organoids. Core 2 incorporates several innovative features in collaboration with Core 3 (Biostatistics and Bioinformatics), including a secure database that houses comprehensive information on collected biospecimens, patient demographics, clinical data, treatment history, and outcomes, as well as the establishment of novel technologies for cellular imaging. Core 2 will also work with Core 1 (Community Outreach and Engagement) to improve strategies for tissue collection in community and academic settings. Thus, Core 2 supports our SPORE to deliver critical resources and technological advancements in the field of lymphoma research focused on improving outcomes for populations.

Public health relevance
Histologic and molecular analysis of lymphoma specimens is central to each SPORE Project, enabling investigators to uncover drivers of disease and develop novel diagnostic and therapeutic strategies. The Biospecimens and Pathology Core provides critical infrastructure for accurate tissue collection pathology review and advanced analysis, including multiplex imaging, spatial transcriptomics, and the development of tissue derivatives and patient-derived xenografts. In collaboration with other SPORE Cores, Core 2 will digitize pathology slides, integrate clinical and biospecimen data, enabling efficient selection of samples with specific molecular, cytogenetic, immunophenotypic, or clinical characteristics for translational studies.